The role of hnRNPK in pancreatic beta cells

Project Summary
Type 2 diabetes (T2D) pathology is complex and multifactorial. Typically, individuals develop insulin resistance
and beta cell compensation that ultimately succumbs to chronic hyperglycemia leading to beta cell failure and
death. By increasing our understanding of the mechanisms and predispositions leading to beta cell demise, we
can begin to develop better strategies and medicines to treat people living with this debilitating disease. It is well
known that beta cells harness transcriptional and post transcriptional controls to increase both the gene and
protein expression of critical proteins that support insulin secretion in response to nutrient stimulation. However,
due to the technical limitations in assessing translational control as opposed to high throughput methods used
to study transcriptional control such as RNA-seq, we have a limited understanding of the mechanisms that
coordinate the rapid translational response of proteins after beta cell stimulation. Our lab has shown that
glucolipotoxicity to mimic the metabolic environment of individuals with T2D stimulates a robust increase in the
translation but not transcription of the transcription factor JUND. This is dependent upon the activity of the RNA
binding protein, hnRNPK, that binds the RNA helicase DDX3X stimulating 18S and preinitiation complex
recruitment and translation initiation. Therefore, the goals of this proposal are to determine the in vivo function
of hnRNPK in beta cells and to decipher the mechanism by which beta cell hnRNPK stimulates translation in
response to metabolic stress. In the first aim, we will utilize our beta cell hnRNPK deletion mouse line to elucidate
the metabolic outcomes of hnRNPK deficiency using glucose and insulin tolerance tests to determine glucose
homeostasis. We will also perform morphometric analyses to determine any effects on beta cell mass or survival
following hnRNPK deletion. In the second aim, we will use co-immunoprecipitation, immunofluorescence, and
gene deletion or reduction to understand how hnRNPK and its interactors regulate the translatome in response
to metabolic stress. Our preliminary data show that male mice devoid of hnRNPK are glucose intolerant and
appear to have reduced beta cell mass suggesting an important role for hnRNPK in beta cells. Furthermore,
hnRNPK and DDX3X share 10 common interactors determined by mass spectrometry upregulated in
glucolipotoxicity conditions that are closely linked to mRNA metabolism and translation in the cell. Using
polysome profiling, we will determine how hnRNPK controls translation under metabolic stress and identify
translationally upregulated transcripts by dissociating mRNA from polysome fractions followed by RNA
sequencing. Using CRISPR-Cas9 and shRNAs in MIN6 cells and isolated islets we can determine the functional
impact hnRNPK or interactor removal has on beta cell translation. Together, these proposed aims will uncover
novel mechanisms underlying protein translation in beta cells mediated by the RNA binding protein hnRNPK.
This will have important implications in our understanding of beta cell function that could be leveraged to aid the
development of better treatments focused on improving beta cell insulin output and survival.

Public health relevance
Project Narrative The development of hyperglycemia, insulin insufficiency, and beta cell failure all underly the progression to Type 2 diabetes. Many efforts have been made to improve the lives of those living with T2D including novel drugs that enhance insulin secretion and induce weight loss but prevalence of this disease is still climbing. Therefore, it is essential the diabetes research community strives to better understand novel mechanisms underlying T2D pathology to help lessen the negative impact this disease has on the world.